Genome analysis: statistical methods and applications

Project Summary
The overall goal of this project is to develop new statistical methods that address important problems in ge-
nomics, to implement them in user-friendly open source software, and to make them available to scientists to
facilitate new biological discoveries. To this end, the proposed work tackles three important problems arising in
genomics where existing statistical methods are lacking, and where new, improved methods could accelerate the
pace of scientific discovery: fine-mapping of functional traits; gene set enrichment analysis (GSEA); and discovering
overlapping cluster structure in genomic data.
The work on fine-mapping will enable the identification of genetic variants influencing common sequencing
assays such as ATAC-seq and ChIP-seq, without pre-specifying the locations of potential effects. This unbiased
approach will help identify regulatory genetic variants and interacting parts of the regulatory genome.
The work on GSEA will provide a new more effective set of tools for researchers who use GSEA to set new
findings in the context of known biology. The proposed work uses recently-developed statistical techniques
to substantially reduce the redundancy of enriched gene sets, and will provide researchers with succinct and
precise results that better highlight the full range of known biological factors that are relevant to a new set of
findings.
The work on overlapping cluster structure will provide new generally-applicable methods for understanding
complex layered and hierarchical relationships that occur commonly in genomics applications (e.g. cell sub-
types nested within cell types, layered on top of patient effects).
The tools developed here will help scientists tackle a diverse range of analysis problems that arise in ge-
nomics, ultimately helping them better understand the biology of disease, with the eventual goal of improving
therapies and treatment strategies.

Public health relevance
Project Narrative Public health relevance: This project will generate and apply statistical tools for analyzing large-scale genomic studies. The tools will help scientists tackle a diverse range of problems, including understanding the effects of genetic variation on fundamental biological processes, identifying collections of related genes that may help inform or explain new experimental results, and discovering relationships and clustering among samples (e.g., cells, genes or people), for example to identify cell or disease sub-types. Solving these problems has the potential to help understand the biology of disease, eventually leading to new therapies or treatment strategies.